Colorado Clinical and Transational Sciences Institute

Funded by NIH in 2008 and 2013, the Colorado Clinical and Translational Sciences Institute (CCTSI) at the
University of Colorado Denver (CU-D) has taken impressive steps to transform and improve the biomedical;
research and training enterprise in the Colorado region and to accelerate and catalyze the translation of
discoveries into improved patient care and public health. The CCTSI, a partnership of CU-D, CU Boulder (CU-
B), Colorado State University (CSU), six hospitals and 20 community organizations, has established new
infrastructure, streamlined processes and expanded existing resources and services for investigators and
stakeholders; tripled the number of training and education programs supporting development of a translational
workforce; administratively centralized and expanded the breadth of clinical research capacity and expertise;
established system-wide informatics capabilities; promoted team science and interdisciplinary research;
established an extensive community engagement program and enhanced research across the lifespan;
streamlined processes and reduced start-up times for trials; created an academic home for clinical & translational
scientists and trainees; and actively engaged in CTSA network activities. Despite these successes, there remain
many challenges to accelerating the translational research process locally and nationally. This application
maps our path forward to meet these challenges. Through 2018 CTSA funding, we will develop new methods,
innovations, expertise, and procedures to: a) achieve a new level of measurable performance in training
translational teams, b) improve efficiency and quality of the full spectrum of translational research, c) facilitate
multi-site clinical trials, d) engage regional communities and stakeholders as partners, and e) collaborate and
disseminate best practices into the national CTSA consortium to accelerate the translation of discoveries into
improved health and patient care. We will accomplish these objectives by embracing the following five Overall
Strategic Goals: Goal 1: Develop, educate and sustain a diverse translational science workforce to ensure
highest research innovation, quality and safety. Goal 2: Create a translational research environment in which
team science and collaboration both locally and nationally are facilitated, supported and valued. Goal 3: Engage
local and national communities and stakeholders in all phases of the translational research process. Goal 4:
Create novel methodologies and resources to support and integrate research in special populations, including
children, the elderly, the underserved and those with rare diseases. Goal 5: Further innovate and streamline
our processes and enhance our informatics capacity for research start-up, implementation and oversight to
promote quality, efficiency, & safety of our research and our active participation in the national CTSA Trial
Innovation Network. Special efforts will be made to enhance diversity in our workforce. Our progress will be
monitored by our Evaluation Core and we will make mid-course corrections as needed to achieve these goals
and ultimately improve the health of our state and the nation.

Public health relevance
The Colorado Clinical and Translational Sciences Institute (CCTSI) is a collaboration between University of Colorado Denver, University of Colorado Boulder, Colorado State University, 6 hospitals and 20 community organizations aimed at translating discoveries into better public health and patient care. Through a variety of programs, the CCTSI will facilitate the performance of high impact research and the training of the next generation of clinical-translational researchers. Emphasis will be placed on accelerating the pace by which research and clinical trials can be conducted while protecting the safety of research participants in order to bring new effective treatments to patients sooner. Ongoing evaluation of our programs will assure that resources are allocated in a cost-effective manner.